The ER-mitochondria interface in astrocytes during METH exposure and HIV-1 infection

Astrocytes are key regulators of CNS health and neuronal function. Astrocyte mitochondrial dysfunction,
such as induced by HIV-1 and METH, threatens the provision of essential metabolic and antioxidant support to
neurons. Thus, delineating regulatory pathways that can be targeted to prevent aberrant mitochondria
homeostasis in astrocytes will be imperative for ensuring neuronal fitness/survival against CNS pathologies.
Direct contact sites between the endoplasmic reticulum (ER) and the mitochondria, termed mitochondrial
associated membranes (MAMs), are central hubs for regulating several cellular processes required for
homeostasis, including mitochondrial metabolic activity. In fact, the transfer of Ca2+ from the ER to mitochondria
is essential for mitochondrial bioenergetics. Recent investigations have also identified unique, yet ill-defined
contributions of the three unfolded protein response (UPR) arms in regulating MAM tethering and/or signaling.
Briefly, protein kinase RNA-like endoplasmic reticulum kinase (PERK) has been determined as a key regulator
for MAM tethering, inositol-requiring kinase 1 (IRE1α) is implicated in regulating MAM-mediated Ca2+ transfer,
and activating transcription factor 6 (ATF6) is suspected to participate in MAM formation as it is known to mediate
ER elongation and lipid homeostasis. However, these regulatory mechanisms have not yet been fully elucidated.
Moreover, while modifications in MAM tethering and signaling have been involved in a number of
neurodegenerative pathologies, their presence and participation in astrocyte biology remains to be determined.
We hypothesize the ER-mitochondria interface is a key mediator of astrocyte mitochondrial dysfunction
via Ca2+ and non-canonical UPR signaling during HIV-1 and METH pathogenesis.
The proposed studies will examine changes in astrocyte mitochondrial function, UPR induction, Ca2+
signaling, and MAM formation in response to METH exposure and HIV-1 infection, followed by the delineation
of ER-associated mechanisms regulating astrocyte mitochondrial function, and thus metabolic and antioxidant
capacity. Aim 1 will evaluate how METH exposure and HIV-1 infection alter astrocyte metabolic and antioxidant
capacity. Aim 2 will investigate how the ER-mitochondria interface regulates HIV-1/METH-mediated astrocyte
mitochondrial dysfunction. Based on our preliminary findings, we propose to prioritize investigating the roles of
PERK and IRE1α in regulating MAM tethering and MAM-mediated Ca2+ transfer, respectively, and how these
functions alter astrocyte mitochondrial capacity. These studies will implement pharmacological inhibitors, specific
silencing (si)RNAs and overexpression vectors to determine how UPR induction, Ca2+ signaling, and MAM
tethering regulate astrocyte mitochondrial health during HIV-1/METH pathogenesis. These findings will help
identify underlying mechanisms mediating astrocyte mitochondria dysfunction, which can be therapeutically
targeted to optimize the metabolic and antioxidant coupling between astrocytes and neurons to promote neuronal
survival during neurodegenerative pathologies.

Public health relevance
Project Narrative: Many people living with HIV and/or substance use disorder struggle with neurological impairments that affect their daily lives. This F31 training research project seeks to evaluate how HIV and methamphetamine regulate cellular stress responses in key neuro-supportive brain cells. A better understanding of these mechanisms will help identify new therapeutic targets to treat or prevent these neurological issues, while concurrently supporting the training of an up-and-coming scientist for an independent career in academia.